Does the Neighborhood Environment Modify Genetic Risk for Cognitive Decline?

DESCRIPTION (provided by applicant): Dementia is a common and disabling brain disorder among older adults that has consequences for independence, functional decline, institutionalization, and mortality. Previous research has identified multiple biological, genetic, and behavioral factors that are associated with cognitive impairment and decline. For example, a relatively common polymorphism in the apolipoprotein E (ApoE) gene, the e4allele, is strongly associated with cognitive decline and is significantly higher among those with Alzheimer's disease compared to rest of the population. Recently, a parallel literature has looked beyond individual-level factors to consider the role of the social and built environment. Findings suggest that residence in socioeconomically advantaged neighborhoods may promote cognitive function and/or buffer cognitive decline in part through their greater density of physical resources (recreational centers, gyms, parks, walking paths) as well as social and institutional resources (libraries, bookstores, community centers, social clubs) that promote physical activity and facilitate mental stimulation. However, an interesting question remains as to whether there are specific sub-populations of older adults who may especially benefit from residence in resource-intensive neighborhoods by virtue of the fact that they are at higher risk for cognitive decline because they carry the e4 allele. We propose to conduct a secondary analysis of data from the Chicago Health and Aging Project, a prospective NIA-funded population based cohort study of older adults in the city of Chicago who were surveyed 5 times over a 16 year period (1993-2009). In addition to being a longitudinal study collecting genetic markers for dementia (APOE e4allele), the study also collected objectively measured, detailed environmental data (including the presence of parks, trees, libraries, churches, community centers). As such, the data provide an ideal opportunity to examine the possible role of neighborhood environments in modifying cognitive decline among older adults who are genetically at risk. PUBLIC HEALTH RELEVANCE: An estimated 5.4 million people in the U.S. over age 70 have cognitive impairment, with consequences for quality of life, functional decline, institutionalizatin, and mortality. Although people with severe impairment in cognition may be concentrated in institutions, the majority of older adults with cognitive impairment live in the community. The proposed research builds on earlier work demonstrating the cognitive benefits of living in resource intensive neighborhoods, by examining whether these benefits are particularly salient in attenuating cognitive decline among older adults who are genetically at risk.

Public health relevance
An estimated 5.4 million people in the U.S. over age 70 have cognitive impairment, with consequences for quality of life, functional decline, institutionalizatin, and mortality. Although people with severe impairment in cognition may be concentrated in institutions, the majority of older adults with cognitive impairment live in the community. The proposed research builds on earlier work demonstrating the cognitive benefits of living in resource intensive neighborhoods, by examining whether these benefits are particularly salient in attenuating cognitive decline among older adults who are genetically at risk.